Placating death eaters: Tuning macrophage metabolism and phenotype via nanoparticles

Project Summary: The immune system plays a pivotal role in tissue healing after traumatic injury and in chronic
inflammation associated with autoimmune diseases. Macrophages are professional phagocytes (cell-eating
cells) of the innate immune system that ingest apoptotic cells (ACs) for nutrient recycling and cellular turnover to
maintain tissue-level homeostasis. Internalization of ACs (known as efferocytosis) has long been known to be a
trigger for the phenotypic switch of macrophages into a reparatory state. Furthermore, dysregulation of
efferocytosis has been shown to contribute to pathologies such as atherosclerosis, cancer, and rheumatoid
arthritis. Interestingly, the processing of apoptotic cellular cargo by macrophages releases metabolites (such as
nucleotides, amino acids, polyamines, lactate, and fatty acids) that alter the metabolic status of the phagocytes—
promoting fatty acid oxidation (FAO) and pro-reparatory phenotype. Here, we will test the hypothesis that this
physiological pro-healing response can be triggered in macrophages via nanoparticle-based delivery of AC-
mimetic metabolite payloads. We have developed a simplified AC-mimetic cargo-delivery system based on
cyclodextrin nanoparticle (CDNP), which is known to be rapidly and preferentially uptaken by macrophages.
Here, we will (a) sequester fatty acid payloads within CDNPs (providing “the fuel” for FAO), (b) encode
immunomodulatory diamines (such as putrescine and spermidine) directly within the CDNP core, (c) test the
uptake of loaded CDNPs by macrophages in vitro, and (d) examine the temporal changes in the transcriptome
and functional phenotype of macrophages that result from CDNP uptake. Using primary murine and human
macrophages in vitro, we will test if cell-targeted delivery can produce transcriptomic and translational signatures
indicative of reparative phenotype. Macrophages will be monitored via morphometric (fluorescence microscopy),
transcriptomic (nanoString), and proteomic (Luminex) tools for phenotyping. Results will demonstrate the
propensity for stimuli (diamines as “the spark”) and a metabolic driver (fatty acids as “the fuel”) to act either
individually or synergistically to promote a reparative state. We will determine the uptake mechanism of CDNPs
loaded with lipid cargo—identifying critical cell-surface receptors, endosomal escape routes of metabolites into
the cytosol, and the intracellular signaling mechanisms. Metabolic changes, such as increase in FAO, will be
studied using Seahorse assay and mass spectrometry. Finally, we will test whether the metabolism-targeted
strategy of macrophage phenotypic modulation can synergize with pharmacologic strategies (e.g., delivery of
anti-inflammatory drugs) for developing an effective therapeutic modality to prevent chronic inflammation.
Completion of these aims would validate the feasibility of metabolic reprogramming of macrophage phenotype
via nanoparticle-mediated intracellular delivery of AC-mimetic metabolites. Although our proposed project is
limited in scope to in vitro studies, its success will enable the healing potential of the innate immune system to
be harnessed for regenerative medicine, including in the context of traumatic injury or autoimmunity.

Public health relevance
Project Narrative: Immune cells that eat other cells play a critical role in chronic inflammation and the resolution of tissue injury. The proposed project will develop nanoparticles to target such immune cells to improve our understanding of cellular components that promote tissue healing. The project will provide practical tools to modulate inflammation in the context of tissue injury and autoimmune diseases.